Beyond Odor Receptors: Molecular basis of insect olfaction

Complex organisms such as vertebrates and insects have developed specialized chemosensory organs in order
to locate food, evaluate mates, and avoid toxins. The sensing of volatile odors is particularly challenging because
odors are often present at low levels in turbulent plumes, yet many animal behaviors rely on the faithful coding
of odor signals by olfactory receptor neurons. The past few decades have witnessed an explosion of research
into olfactory systems, following the cloning of the first odor receptors. Initial research focused on understanding
odor receptor function, characterizing their odor response profiles, and understanding their effects on behavior.
However, many open questions remain regarding the molecular and cellular mechanisms supporting olfaction in
the periphery, particularly in regards to insect olfaction. What signaling mechanisms are downstream of insect
odor receptor activation? How are odors removed from the peri-neuronal space? What contribution do non-
neuronal support cells make to olfactory neuron activity? How are the support cells of olfactory sensilla similar
or different than those in sensilla that mediate other sensory modalities? My lab seeks answers for these
questions in the Drosophila antenna, their primary olfactory organ. This versatile model organism is
advantageous for such studies because we can exploit the large number of available genetic tools and existing
knowledge on its stereotyped receptor and neuronal organization.
Here we propose to study the functions of several candidate genes that have arisen from our recent
computational screen, and may provide answers to several outstanding questions in field olfaction field as
described above. One project centers on several highly conserved antennal-enriched signaling genes and their
putative roles in amplification and desensitization downstream of odor receptor activation. Two additional
projects focus on the interactions between non-neuronal support cells and the signaling of olfactory neurons.
One investigates the role of support cells in odor degradation using candidate metabolic genes that arose from
our screen and an RNASeq-based method to identify new candidates. We will also elucidate the potential
differences in function between the major support cell classes, which are found not only in olfactory sensilla but
also in sensilla that mediate other physiological functions.

Public health relevance
Project Narrative Many organisms rely on their sense of smell to locate and evaluate food sources, but it is particularly important to understand olfactory signaling in insects due to their transmission of lethal diseases such as malaria. This study proposes to identify molecular and cellular mechanisms that support the initial steps of olfactory signaling in the antennae of Drosophila fruit flies, a genetically tractable model organism. This research may lead to new targets for the development of insect control agents, and can reveal first principles supporting the sensing of odors in more complex organisms.